Structure and function of DNA polymerase lambda opposite DNA lesions which disrupt Watson-Crick base pairing

DNA polymerase (Pol) ζ, a B-family Pol, plays an important role in replication of damaged DNA. Extensive biochemical studies with Polζ have shown that it is very inefficient at inserting nucleotides (nts) opposite DNA lesions but is highly efficient at extending synthesis from the correct or incorrect nt opposite DNA lesions. Since translesion DNA synthesis (TLS) through a large variety of DNA lesions requires the sequential action of an inserter and an extender Pol, by extending synthesis opposite from diverse DNA lesions, Polζ performs a critical task in the replication of damaged DNA. In yeast, Rev1 performs an indispensable but non-catalytic role as a component of Polζ?? and it increases Polζ’s efficiency for extension from incorrect nts opposite DNA lesions. Consequently, the Rev1/Polζ complex promotes highly error-prone TLS and thereby accounts for damage induced mutagenesis in yeast. In striking contrast to the requirement of Rev1 for yeast Polζ function, Rev1 is not required for Polζ function in TLS in normal human cells. Instead, we provide evidence here that Polλ acts as an indispensable component of human (h) Polζ? and in concert with Pol?, hPolζ promotes a predominantly error-free mode of TLS opposite various DNA lesions. In the proposed studies, we will utilize a combination of genetic, cellular, biochemical, and structural studies to: elucidate the role of Polλ in Polζ dependent TLS in human cells, determine the fidelity and action mechanism of Polλ in TLS opposite DNA lesions which impair Watson-Crick (W-C) base pairing, and define the molecular mechanisms that allow Polλ’s active site to handle such DNA lesions. In Aim 1, we will: (a) analyze the requirement of Polλ and its domains for Polζ-dependent TLS and mutagenesis opposite a variety of DNA lesions in human cells; (b) examine the role of Polλ in UV induced mutagenesis in the cII gene carried in the mouse genome; (c) determine the requirement of Polλ domains for localization of Polζ?into replication foci in UV damaged human cells; (d) examine whether Polλ associates with hPolζ in a physical complex in UV damaged human cells; and (e) determine the effects of Polλ on fork progression in UV irradiated human cells. In Aim 2, we will (a) use steady-state kinetic analyses to determine the catalytic efficiency and fidelity of Polλ in inserting nucleotides opposite N1-methyladenine (N1-MeA) and the 3′T and 5′T of a (6-4) TT photoproduct, and (b) carry out pre- steady-state kinetic studies to determine the action mechanism of Polλ for inserting the correct nt opposite these DNA lesions which impair W-C base pairing. In Aim 3, we will (a) determine the structures of binary and ternary complexes of Polλ bound to N1-MeA template in the absence or presence of an incoming dTTP, respectively, (b) determine the structures of binary and ternary complexes of Polλ bound to the (6-4) TT photoproduct-containing templates in the absence or presence of an incoming dATP, respectively, and (c) carry out mutational analyses of residues deemed from the structures as important for stabilizing the damaged template.?

Public health relevance
DNA polymerase  (Pol) plays a key role in the replication of damaged DNA. We identify DNA polymerase  (Pol) as an indispensable component of Pol in human cells, and propose a combination of genetic, cellular, biochemical, and structural studies to elucidate the role and action mechanism of Pol opposite DNA lesions which disrupt Watson-Crick base pairing.